Training Program in Endocrinology and Metabolism

Abstract
The University of Michigan Research Training Program in Endocrinology and Metabolism, now in its 43rd
continuous year, prepares postdoctoral MD, MD/PhD, and PhD scientists for careers as academic investigators
in the broad discipline of endocrinology and metabolism. This program recruits talented applicants for the
Research Track of the Endocrinology Fellowship at Michigan and selected PhD scientists to pursue structured,
mentored, and rigorous research training with established and successful faculty members, which ranges from
basic research to translational clinical investigation. This training includes instruction in experimental and study
design; laboratory and clinical investigation techniques; data analysis and statistical methods; writing abstracts,
posters, manuscripts, grant proposals, and reports; preparing and delivering oral presentations; rigor and
reproducibility; and responsible conduct of research. The two major themes of research are: 1) the hormonal
regulation of metabolism and energy balance; 2) the development and regulation of endocrine glands, hormone
production, and endocrine tumors. Our mission is to prepare the next generation of academic endocrinologists
and selected PhD scientists for successful careers in basic, translational, and patient-oriented research in
endocrinology. To accomplish this mission, we have developed a program that combines unparalleled clinical
training opportunities, a diverse spectrum of outstanding research opportunities, and individualized mentoring
for postgraduate scholars possessing MD and/or PhD degrees. Many trainees will be endocrinology fellows, who
are appointed to the Program following a year of comprehensive exposure to inpatient and outpatient
experiences in endocrine disorders for at least 2 years of protected research training. The program features 24
experienced faculty mentors with external funding and diverse, active research programs. The PI oversees the
program through the governance of an Advisory Committee, which is separate from but functions in parallel to
the Fellowship Steering Committee.

Public health relevance
Project Narrative This program trains physician-scientists and postdoctoral scientists in many areas of endocrinology research. The major themes are the hormonal regulation of metabolism and energy balance as well as the development and regulation of endocrine glands, hormone production, and endocrine tumors. Our mission is to prepare the next generation of academic endocrinologists and selected PhD scientists for successful careers in basic, translational, and patient-oriented research in endocrinology.